Illuminating development of infant and toddler brainfunction with DOT

Project Summary/Abstract
The long-term goal of these studies is to advance high-density diffuse optical tomography (HD-DOT) methods
for evaluating brain-behavior relationships in infants and toddlers at risk for developing autism spectrum disorder
(ASD) while they are awake and engaged within a naturalistic setting. This application is being submitted in
response to FOA: RFA-MH-18-200, NIMH Biobehavioral Research Awards for Innovative New Scientists
(BRAINS R01), because the PI is an early stage investigator who is building a program of research that is highly
innovative, transformative, and has the potential to elucidate underlying mechanisms, inform clinical
interventions, and improve outcome of ASD. As such, this research is harmonious with the mission of NIMH: to
transform the understanding and treatment of mental illnesses through basic and clinical research, paving the
way for prevention, recovery, and cure. ASD, defined by deficits in social communication and restricted
interests/repetitive behaviors, is a serious psychiatric disorder of childhood, is treatable but currently incurable,
and affects an estimated 1 in 59 children in the United States at an estimated annual cost of $268B. Early
behavioral and educational interventions, starting at 18-24 months of age, improve outcomes in a subset of
patients. Neuroimaging methods, including both task-based functional magnetic resonance imaging (fMRI) and
task-free functional connectivity MRI, have demonstrated sensitivity to neural signatures of ASD that may inform
diagnosis and track responses to interventions. However, the MRI environment can prove intolerable for many
children due to noise, claustrophobia, and the need to lie supine and still. HD-DOT provides a compelling
alternative that overcomes the significant ergonomic limitations of fMRI and silently images brain function with a
wearable cap in a naturalistic setting ideal for studies on awake and engaged infants and toddlers. However,
studies in young children over multiple imaging sessions present significant challenges in optical data registration
and fidelity that motivate a new set of software tools to enable accurate and reliable mapping of brain function.
Here we address these needs by developing novel algorithms for photometric head modeling and data fidelity
management. With these advancements, we will conduct a prospective longitudinal study of brain function and
behavior in toddlers at risk for developing ASD. Specifically, we will measure neural signatures derived from
naturalistic movie viewing, determine the relationship between these signatures and behavioral assays across
development, and investigate how these signatures are affected in toddlers at risk for ASD in a case-control
sample. These data may provide markers to the specific aspects of impaired behavior observed in ASD, namely
affected social communication, receptive and expressive language, motor coordination disruption, and even
restricted and repetitive behaviors. Further, this strategy provides a diversified approach to assessment that will
be applicable across development, and may facilitate identification of common mechanisms by which disparate
genetic pathways to autism result in the broad autistic phenotype.

Public health relevance
Project Narrative It is estimated that ~1/59 children are affected with Autism Spectrum Disorder (ASD), one of the most serious psychiatric disorders of childhood, defined by deficits in social communication and restricted interests/repetitive behaviors. Recent advances in functional brain imaging show promise that pre-diagnostic neural signatures for ASD may provide useful risk markers and may even be sensitive to responses to interventional therapies that have been shown to improve quality of life. In this R01 proposal, we will extend high density diffuse optical tomography methods, which can silently image brain function in a naturalistic setting and have the potential to be useful for pre-symptomatic risk monitoring, for an innovative and prospective longitudinal study of awake and engaged infants and toddlers at risk for developing ASD.